Project 3: Pharmacogenomic advancements for improved treatment of acute lymphoblastic leukemia in Latino children and adolescents

Project 3: Pharmacogenomic advancements for improved treatment of acute lymphoblastic leukemia in
Latino children and adolescents
Project Summary
There is existing and emerging evidence that germline genetic variants can strongly influence the risk of toxicity
of acute lymphoblastic leukemia (ALL) therapeutics and supportive care medications. For example, variants in
TPMT and NUDT15 are known to confer an increased risk of mercaptopurine-induced myelosuppression.
Additionally, recent genomic studies have been instrumental in identifying other novel genes and variants
associated with various treatment-related effects, including but not limited to 1) CPA2 and asparaginase-induced
toxicities, 2) CEP72 and vincristine-induced peripheral neuropathy, and 3) G6PD and rasburicase-induced
hemolytic anemia. These data warrant the emerging effort to incorporate key variants from these genes in clinical
pharmacogenomic (PGx) testing panels for children diagnosed with ALL for use in guiding clinical care. Despite
the promise of clinical PGx panels, key implementation gaps remain, especially among at-risk populations. First,
there have been few efforts to evaluate the frequency of actionable variants among Latino children compared to
children of European ancestry or whether there are differences based on self-reported demographic factors
versus estimated genetic ancestry; these knowledge gaps limit our understanding of the utility of these panels
in all populations. Second, there have been no well-developed clinical trials focused on at-risk populations to
evaluate the impact of returning clinical PGx panel results to families affected by ALL; this limits the ability to
provide these families with effective counseling and recommendations regarding treatment and surveillance
options. Third, the majority of PGx assessments have been conducted among individuals of European ancestry,
which limits the addition of Latino-specific variants on clinical PGx panels that might more accurately predict
treatment-related effects. Based on these gaps, our overall hypothesis is that Latinos experience more
treatment-related toxicity and may particularly benefit from PGx-guided individualization of therapy to mitigate
adverse outcomes. Co-led by Drs. Brooke Bernhardt, Stacey Pereira, Hadley Stevens Smith, and Philip Lupo
Project 3 will leverage the REDIAL Retrospective and Prospective Cohorts to evaluate our hypothesis in the
following aims: 1) Implement a clinical PGx panel in a large population of ALL patients and evaluate clinical and
family-centered outcomes and 2) Identify Latino-specific PGx variants in ALL drug-gene pairs that are associated
with treatment-related toxicities. There is compelling evidence that pharmacogenomics can be leveraged to
mitigate treatment-related effects, particularly toxicities, among Latinos. We will comprehensively address the
implementation of PGx testing and identify novel, Latino-specific PGx-related variants in a population of children
and adolescents with ALL. Ultimately, findings from this project will inform novel risk stratification strategies and
genetic testing protocols among children and adolescents diagnosed with ALL.

Public health relevance
Project 3: Pharmacogenomic advancements for improved treatment of acute lymphoblastic leukemia in Latino children and adolescents Project Narrative There is existing and emerging evidence that inherited genetic variants can strongly influence the risk of toxicity of acute lymphoblastic leukemia (ALL) therapeutics and supportive care medications; however, there are key implementation gaps related to pharmacogenomic (PGx) testing. This project will provide insights into the implementation of PGx testing among children with ALL and will inform how best to include a broader spectrum of variants on future clinical PGx panels.